Cell type specific vulnerability to aging

Project Summary: Cognitive decline is an already significant and increasing public health issue.
Multiple factors contribute to cognitive decline. In particular, hearing is central to human
communication and age-related hearing loss (ARHL, presbycusis) by itself is a common ailment
due to age-related changes along the auditory pathway. Both hearing loss and aging are
associated with cognitive decline, increasing the risk for Alzheimer's disease (AD). In many
cases of presbycusis peripheral function is normal, pointing to a large role of central auditory
system dysfunctions. However, the age-related changes in the central nervous system that
underlie these functional deficits are largely unknown due to the functional and molecular
complexity of central circuits. This lack of knowledge precludes targeted interventions. We
hypothesize that the key changes in normal aging and AD in the central nervous system is the
dedifferentiation of neurons, that is the loss of their functional, transcriptional, and connectional
identities, and that this dedifferentiation occurs more rapidly in AD.
We test this hypothesis by a series of molecular and cellular neuro-imaging experiments
in both aged animals and an AD model, which explores the molecular, connectomic, and
physiological correlates of ARHL and identifies precisely which auditory cortical circuits are
impacted by aging. Based on preliminary data showing that lifelong auditory training can prevent
at least some of the age-related changes in A1, we then develop therapeutic strategies through
plasticity induced by engagement of cognitive functions. To achieve our goals, we integrate at
the level of single cells across large scale single-nucleus RNAseq, spatially resolved STARmap
in situ sequencing, next-generation barcode-based connectomics, and in vivo 2-photon imaging.
We also use training procedures to reverse some of the age-related changes.

Public health relevance
Narrative: Aging and Alzheimer's disease (AD) affect the functioning of our brain and dedifferentiation of the brain is thought to underlie the decreased function. Since hearing problems are associated with both aging and AD, we investigate how aging and AD affect the cortical mechanisms that underlie hearing on a molecular and functional level and also test preventative strategies than can forestall molecular and functional changes. Therefore, our work contributes to the basic understanding of molecular and functional changes with aging and AD.